Role of the alarmone (p)ppGpp in phenotypic antibiotic tolerance

Project Summary
The emergence of pathogenic bacteria resistant to antibiotics is an urgent public health issue.
Resistance typically results from a specific genetic mutation that permanently alters the organism’s
sensitivity to a particular antibiotic. However, antibiotic sensitivity can also change transiently as
the result of phenotypic antibiotic tolerance, a phenomenon that is thought to underly treatment
failures in the case of recurrent bacterial infections. Antibiotic tolerance results from the entry of
bacteria into a transient growth-arrested and quiescent state where they are less sensitive to
compounds that inhibit processes such as DNA replication or cell wall synthesis and thus can
escape killing by antibiotics to which they are normally sensitive. While quiescence is
characteristic of most cells in a stationary phase culture, only a small fraction of the cells in a
exponentially growing culture are transiently quiescent. It is these cells – “persisters” - that are
thought to be responsible for the failure of antibiotic treatment in recurrent infections. How does
quiescence occur in only a sub-population? One proposed mechanism involves the nucleotide
second messengers (p)ppGpp that inhibit a broad range of physiological processes including
transcription and DNA replication leading to growth arrest and quiescence. It has been proposed
that variability in the amount of (p)ppGpp in cells could lead to variations in growth state and
thereby antibiotic sensitivity. We recently found that ~1% of an exponentially growing population
of Bacillus subtilis expresses substantially higher amounts of a (p)ppGpp synthase. The cells in
this sub-population exhibit increased antibiotic tolerance as compared to most cells in the
population that do not express this protein. In an important extension of this work, we have
developed a fluorescent reporter can be used to identify individual cells with elevated levels of
(p)ppGpp. We call these cells (p)ppGpphigh and they can be isolated by Fluorescent Activated Cell
Sorting (FACS). We propose to investigate (p)ppGpphigh cells in the following Aims. Aim 1 is to
characterize the (p)ppGpphigh cells and compare their physiological characteristics including
protein synthesis and DNA replication to average cells of the population. Aim 2 is to investigate
the cellular mechanisms responsible for the synthesis and degradation of (p)ppGpp in the
(p)ppGpphigh cells. The knowledge gained during the course of this project will deepen our
understanding of the physiology of persister bacteria and facilitate the identification of metabolic
vulnerabilities that could serve as potential targets for anti-persister strategies.

Public health relevance
Project Narrative Antibiotics serve as the basic strategy to control bacteria that cause disease because they kill them. However, bacteria can become less sensitive to antibiotics in a way that does not require a permanent change. This proposal aims to understand how this happens with the ultimate goal of identifying inhibitory molecules that prevent it from happening.